Fungal Pathogens: Emerging Threats and Future Challenges

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Fungal Pathogens: Emerging Threats and
Future Challenges, organized by Drs. Michail Lionakis, Sarah Gaffen and Mari Shinohara. The conference will
be held in Banff, Alberta, Canada from February 18-21, 2024.
Human pathogenic fungi have emerged as significant causes of morbidity and mortality in patients with acquired
immunodeficiency conditions such as HIV/AIDS, as well as in receipt of myeloablative chemotherapy and
targeted immunosuppressive therapies for autoimmune disorders, neoplastic diseases, and in hematopoietic
stem cell and solid organ transplantation. Moreover, in recent years, emerging multidrug resistant Candida auris
has been responsible for life-threatening outbreaks in healthcare facilities and raises serious concerns to global
public health. Furthermore, a recent surge in the discovery and characterization of novel monogenic inborn errors
of immunity that have been predisposed to mucocutaneous and/or invasive tissue-specific fungal disease, along
with the development of clinically relevant animal models of mucocutaneous and invasive fungal infections, have
collectively enhanced our understanding of cell type-, tissue-, and fungus-specific recognition, effector pathways,
and adaptive immune responses. These advances, along with our improved molecular understanding of fungal
virulence traits, highlight the promise for rapid development of targeted treatment strategies against fungal
pathogens. Therefore, this Keystone Symposia conference will bring together, for the first time, scientists who
study fungal virulence and fungal immunology, thus helping to synthesize current understanding of the cellular
and molecular determinants of fungal pathogenesis and mammalian antifungal immunity. By encouraging cross-
disciplinary exchange, this conference will advance key priorities of informing precision risk stratification, and
defining prophylactic, therapeutic and vaccination strategies to combat life-threatening fungal infections in
vulnerable patient populations.

Public health relevance
PROJECT NARRATIVE Fungal infections represent significant causes of morbidity and mortality in vulnerable patients across the globe. This Keystone Symposia meeting will bring together scientists in the mycology field to better understand the mechanisms of host-fungal interactions. This is a timely gathering of experts from diverse scientific backgrounds related to fungal biology and fungal immunology who share an ultimate goal of decreasing the burden of fungal infections and improving patient outcomes.